Reprogramming cell-fate decisions through predictive modeling and synthetic biology

Project Summary
Advances in synthetic biology provide powerful tools to interrogate the complex relationship between
network structure and function. In this study, we will combine synthetic biology with computational modeling to
investigate network-mediated regulation of cell damage and deterioration, a complex biological process. As
similar studies in mammals are prohibitively time- and resource-intensive, we choose to focus on
Saccharomyces cerevisiae, which has proven to be a genetically tractable model for many fundamental
processes in mitotic cells and has allowed identification of many conserved genes that regulate cell-fate
decisions in eukaryotes. Emerging questions include how these genes interact and how the interactions change
dynamically to drive multi-generational cell deterioration dynamics. We recently found two distinct phenotypes
in genetically identical yeast cells as they approach cell death: one with decreased ribosomal DNA (rDNA)
silencing and nucleolar decline (Mode 1) whereas the other with heme depletion and mitochondrial decline (Mode
2). We found that stochasticity plays an important role in choosing one of the two paths, but once the fate decision
is made, it is almost always irreversible. We identified a core molecular circuit, consisting of the lysine
deacetylase Sir2 and the heme-activated protein (HAP) transcriptional complex, that governs the decision to
select one of these two paths. Based on the model, we were able to engineer cells to follow a third path with a
dramatically extended period of growth and survival, free of deterioration (Mode 3). In this proposal, we will
expand these efforts and systematically perturb and rewire the core circuit that controls cell fate in order to
reprogram its decision-making process. In Aim 1, we will use chemically-inducible promoters to control
expression of Sir2 and HAP and thereby modulate cell-fate decisions in isogenic cells. We will use microfluidics
to generate distinct, dynamic patterns of Sir2 and HAP expression and evaluate their effects on damage
accumulation, physiological changes, and cellular decline. In Aim 2, we will genetically rewire the core Sir2-HAP
circuit under the guidance of computational modeling and examine how these engineered circuits govern cell-
fate decisions and cell deterioration dynamics. In Aim 3, we will use high-throughput microfluidics to identify the
gene expression programs associated with Mode 1, Mode 2, and Mode 3 and examine how perturbations of
these programs affect multi-generational deterioration dynamics. These analyses will uncover the genes and
processes that underlie the missing connections between the Sir2-HAP core circuit and downstream modules
that underlie cellular decline leading to cell death. They will enable us to expand our computational model and
improve its predictive power. Throughout the study, we will construct deterministic and stochastic models, which
will produce testable predictions and guide engineering of synthetic gene circuits. If successful, this research will
advance a quantitative and predictive understanding of cellular fate decisions and cell deterioration.

Public health relevance
Project Narrative Synthetic biology holds the promise of transforming the development of diagnostic and treatment strategies for various diseases. This project applies synthetic biology approaches to reprogram fate decisions toward progressive cellular deterioration, a key factor in many diseases, such as cancers, diabetes, and neurodegenerative diseases. Key insights obtained from this project will define foundations for chemical or gene- based strategies to treating diseases related to progressive cellular deterioration.